Training Program in Cardiometabolic Diseases

PROJECT ABSTRACT
This is the second competing renewal application for a Ruth L. Kirschstein Institutional National Research
Service Award (T32), which was originally established in 2009 to provide closely mentored, multidisciplinary
postdoctoral research training to highly promising physician-scientists and PhDs and prepare them for careers
as independent cardiovascular investigators. Since its inception, we have enrolled a total of eighteen trainees,
including two under-represented minorities. Almost all graduates of our program have contributed significantly
to the cardiovascular literature and a substantial proportion have obtained full-time academic or industry
positions engaged in biomedical investigation. Four graduates of the program have been recruited to the
faculty of our Division of Cardiology as full-time physician-investigators and all have competed successfully for
independent NIH or AHA funding. There are two major changes in this competing renewal application. First,
reflecting the growing cadre of faculty at NYU School of Medicine investigating cardiovascular complications of
diabetes and metabolic disorders and the tight integration of research in our Divisions of Cardiology and
Endocrinology, in this renewal we have renamed this T32 the Training Program in Cardiometabolic Diseases
and have named Dr. Ira Goldberg, Director of Endocrinology to the role of co-Program Director (PD). Second,
as an anticipated consequence of implementing the ABIM Research Pathway and Clinical Investigator
Pathway into our Internal Medicine residency program, we have a growing pipeline of highly talented MD and
MD/PhD fellows seeking intensive postdoctoral research training program as the next step in their goal of
launching independent research careers. Therefore, we are requesting an expansion of this T32 training
program to six positions each year. As in the past, the training program is built upon a foundation of highly
accomplished and experienced NIH-funded primary faculty members. The curriculum includes rigorous
didactics, a personalized mentoring plan, and an intensive research experience. The training program begins
with a broad-based educational curriculum that provides all trainees with a fundamental knowledge-base that
stresses research tools and the interface between biomedical research and important manifestations of
cardiovascular disease. Trainees will then pursue more specialized coursework and embark upon a substantial
laboratory-based or clinical research project under the guidance of a Primary Mentor in one of several areas of
institutional strength: Myocardial/Ion Channel Biology and Disease; Vascular Biology and Disease; Metabolic
Causes of Cardiovascular Disease, and Clinical Research. Given our track-record, we are confident that
continued support for this program will produce a steady pipeline of highly talented and motivated investigators
who are committed to enhancing cardiovascular/cardiometabolic health in the United States and elsewhere.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease remains the major cause of death in the US. Through the renewal and expansion of this highly successful postdoctoral training program, we align ourselves with the stated goal of the NHLBI to “provide a sustained flow of qualified physician-scientists able to think critically and translate findings freely between the basic and clinical spheres.” We will accomplish this goal through strong mentorship by established experts in the field, specialized didactics, and intensive training through basic, translational and/or clinical research projects tackling the major forms of cardiovascular disease.